Maintenance of the Hematopoietic Stem Cell Niche Monocytes and Macrophages

DESCRIPTION (provided by applicant): Mobilization of hematopoietic stem and progenitor cells (HSPCs) into the peripheral blood has made harvest of donor cells for bone marrow (BM) transplantations more convenient and improved cell yield and engraftment. HSPC mobilization by G-CSF (Filgrastim) is mediated by modulation of the stem cell niche, which is the BM microenvironment that retains and regulates HSPCs. There have been many hints in the literature that monocytes and macrophages control the hematopoietic niche. This application proposes to study the role of the M-CSF receptor (CD115)-expressing cells in the maintenance of the HSC niche. Our preliminary data indicates that G-CSF reduces BM monocyte and macrophage numbers and in vivo depletion of these populations is correlated with HSPC mobilization and reduction in BM CXCL12, an HSPC retention chemokine. In this proposal, 1 will a) confirm this correlation in two additional in vivo models of CD115+ cell depletion, b) identify the factors mediating cross-talk (via microarray of CD115+ cells co-cultured with a murine BM-derived stromal cell line and protein array of culture supernatant), c) determine dependence of CDI 15-depletion-induced mobilization of HSPC on the sympathetic nervous system (using pharmacological, surgical and genetic models of sympathectomy), and d) elucidate synergy of this mobilization with other mobilizing agents (G-CSF and AMD3100). For aims a, c, d, e, I will assess HSPC mobilization by colony forming assays, CD115+ cell reduction by flow cytometry, and reduction in CXCL12 chemokine by ELISA. PUBLIC HEALTH RELEVANCE: While stem cell mobilization has made retrieval of donor cells for transplants more convenient and efficient, it yields an insufficient number of stem cells in up to 40% of patients. The experiments proposed can potentially lead to the development of new strategies targeting the BM monocytes and macrophages to maximize stem cell yield. The results of this project also has broad implications for the maintenance of non-hematopoietic stem cell niches, whose manipulation can be instrumental in facilitating tissue repair after injuries, such as myocardial infarction, traumatic burns, and neurodegeneration.